Role of EphB4-ephrin-B2 interaction in regulating crosstalk between cancer cell and vascular tumor microenvironment in head and neck cancer

1 The outcomes for high-risk HPV-negative head and neck squamous cell carcinoma (HNSCC) remain poor
2 despite aggressive therapy. One possible explanation is the development of therapeutic resistance by aberrant
3 regulation of tumor angiogenesis. The receptor tyrosine kinase receptor, EphB4, and its membrane-bound
4 ligand, ephrinB2 (EFNB2), can both signal and have been shown to play pro-tumorigenic and pro-angiogenic
5 roles in numerous malignancies and in early embryonic development. Our data demonstrate strong correlation
6 between elevated gene expression of EphB4 and EFNB2 and survival outcomes in HPV negative HNSCC
7 patients. We show that EphB4 is predominantly expressed on cancer cells and EFNB2 is predominantly
8 present on endothelial cells (EC). Our data also show that targeting HNSCC tumors with a recombinant fusion
9 protein that blocks EphB4-EFNB2 interaction enhances cancer cell apoptosis, reduces
10 angiogenesis/lymphangiogenesis, and decreases tumor growth in patient-derived xenograft models. This, we
11 demonstrate, is associated with an increase in FasR, Bax, Bim, and caspase 3 cleavage apoptotic markers as
12 well as a decrease in VEGFR2/3, JAK2 and Stat3 signaling components. Based on these data, we hypothesize
13 that the interaction between EphB4 and EFNB2 at the cancer-EC junction simultaneously leads to activation of
14 survival and anti-apoptotic pathways for the cancer cell and angiogenic pathways for the EC. Therefore, we
15 propose, its inhibition will decrease tumor vascular/lymph angiogenesis and decreases cancer cell apoptosis.
16 This EphB4-EFNB2 interaction defines a novel cancer-EC “synapse,” where the focus is on the crosstalk and
17 not just on ECs, thus providing an opportunity for greater therapeutic efficacy than the currently available anti-
18 angiogenic therapies. In Aim 1, we will differentiate the compartmental effects of targeting the EphB4-
19 expressing cancer cell versus EFNB2-expressing ECs, by using an EFNB2 inducible knockout murine model
20 with selective deletion of EFNB2 in the adult ECs. Mouse HNSCC cell lines with shRNA and dominant negative
21 (DN) knockdown of EphB4 on cancer cells will be implanted and perfusion and immunofluorescence will be
22 used to assess effects on growth and angiogenesis/lymphangiogenesis. In Aims 2 and 3, in-depth interrogation
23 of signaling mechanisms underlying EphB4-EFNB2 interaction will be tested on in vivo tissue as well as
24 cancer-EC co-culture assays using shRNA and DN knockdowns for EphB4 and EFNB2. Targeted inhibition of
25 JAK2-STAT3-ERK and FasR, BAX, and PI3K will be done with genetic and pharmacologic inhibitors to assess
26 their role in vascular sprouting and cancer cell apoptosis. Proximity ligation assay will be done to evaluate
27 intracellular and intercellular interactions. Finally, tissue from the in vivo mouse model as well as from a clinical
28 trial incorporating an EphB4-EFNB2 inhibitor in HNSCC will be assessed using RNAseq, angiogenic, and
29 apoptotic arrays. Understanding the mechanistic underpinnings of interaction between the vasculature and
30 cancer cell will break down barriers that have stymied the angiogenesis field for decades.

Public health relevance
Narrative Treatment options for high-risk HPV-negative head and neck cancer patients mainly consist of a combination of radiation therapy and chemotherapeutic drugs. Unfortunately, a significant proportion of patients still suffer treatment failure due in part to rich tumor vascular and lymphatic network. This research proposal examines how interfering with crosstalk between two proteins, EphB4 and ephrin-B2 (expressed on cancer cells and tumor vessels, respectively), will block tumor growth by inhibiting tumor blood supply and cell death pathways.